Diversity of Presynaptic Function Among Neuronal Populations

ABSTRACT
Tight regulation of neurotransmitter release is critical for normal brain function. After decades of research, we
understand the general mechanism of this process, but this reflects the average synapse. The brain uses a
variety of neurotransmitters that differ in the architecture of the release site, the time scale of signaling and the
effect they have on the activity of the target cell with less understanding of differences in corresponding
presynaptic regulatory mechanisms. We compared the subcortical glutamate system that assures fast and
reliable rely of information with dopamine neurons that release a slow acting modulatory transmitter in a
frequency dependent manner. We found that the release of these two transmitters differs in frequency
dependence and that dopamine and glutamate are stored in functionally distinct synaptic vesicles even if
released from the same neuron. Further comparison of the vesicles that store monoamines or glutamate by
mass spectrometry revealed differences in protein composition. The proposed research aims to understand how
differences in presynaptic machinery affect the properties of dopamine and glutamate release. We will address
the role of SV replenishment pathways in generating molecular diversity in synaptic vesicle composition and
function. Also, since SV replenishment after fusion includes poorly understood quality control steps that include
decisions regarding the reuse or degradation of SV proteins, we will focus on cell type and SV retrieval pathway
dependent differences in protein homeostasis machinery at the presynaptic terminal. Altogether, this project will
provide insight into presynaptic function in monoamine neurons and increase our understanding of the molecular
factors that regulate neurotransmitter release probability. The proposal also addresses a likely diversity in the
mechanisms of presynaptic protein homeostasis and has the potential to reveal sources of selective vulnerability
of monoamine neurons in neurodegeneration.

Public health relevance
PROJECT NARRATIVE We found that the release of the fast synaptic neurotransmitter glutamate and modulatory transmitter dopamine differs in kinetics and frequency dependence, even if released from the same neuron. By comparing the molecular composition and mechanisms that control the release of these two transmitters, we hope to reveal wider insight into the regulation of neurotransmitter release in the context of volume versus synaptic transmission and to reveal regulators of release probability. We also focus on the role of SV replenishment pathways in generating diversity in synaptic vesicle composition and assuring protein quality control at presynaptic terminals.